Duke/UNC Alzheimer's Disease Research Center

ABSTRACT - OVERALL
Before it kills, Alzheimer’s disease (AD) exacts a devastating toll on patients, families, caregivers, and
communities. Moreover, even in 2020, there is still no prevention or cure for AD. To meet this challenge, the
new Duke/University of North Carolina ADRC is poised to transform AD-related research and services across
the Research Triangle and Eastern North Carolina. The new Duke/University of North Carolina Alzheimer’s
Disease Research Center (Duke/UNC ADRC)’s theme is identifying age-related changes across the lifespan
that mediate development, progression, and experience of Alzheimer’s disease (AD). In support of this theme,
the Duke/UNC ADRC clinical cohort design and biomarker collection equips investigators with data and
resources to discover new opportunities to intervene in the years before AD symptoms manifest. A related
Center goal is to identify how factors that arise in early and mid-life contribute to racial and urban/rural
disparities in dementia. The Center plans to provide infrastructure and resources aligned with the following
specific aims: 1) Stimulate and support research on AD and Alzheimer’s disease-related dementias
(AD+ADRD) for investigators from many fields by providing access to well-characterized subjects, curated data
and biospecimens from diverse individuals across a wide age-spectrum with and without dementia, with
emphasis on pre-clinical and early disease; 2) Attract and prepare diverse, creative, well-trained investigators
to conduct high caliber research on AD+ADRD and 3) Improve lives impacted by age-related cognitive decline
and increase the inclusiveness of this research. The Center’s Cores (Clinical, Biomarker, Neuropathology,
Data Management and Statistics (DMS), Outreach, Recruitment, and Engagement (ORE), Administrative) and
Research Education Component (REC) work collectively to pursue these aims, aided by our team’s decades of
dementia outreach across North Carolina, strong existing ties to minority and rural communities, and
institutional resources and experts in disparities research. The Center’s Clinical, Biomarker, and
Neuropathology Cores, in conjunction with the ORE Core will support collection of images, biospecimens, and
fluids from over 500 well-characterized participants across a broad age range. The DMS Core will support data
curation and analysis by providing integrated data management and statistical/bioinformatics collaborative
expertise. The REC will develop a robust and diverse pipeline of future leaders in AD+ADRD research through
an innovative combination of widely disseminated curricular elements and more personalized mentoring
experiences. The REC’s educational platforms extend to three additional Universities in our catchment area,
including two majority minority institutions. The ADRC’s Cores and the REC, supported by the Administrative
Core, will work in a coordinated manner to generate and store data and resources from people with and
without dementia or AD risk, share data and expertise as widely as possible, and ultimately contribute back to
the AD community through dissemination of results, education, and health services.

Public health relevance
PROJECT NARRATIVE – Overall The Duke/University of North Carolina (UNC) Alzheimer’s Disease Research Center (Duke/UNC ADRC) is a collaboration of leading researchers in aging and Alzheimer’s disease. The Center’s primary objective is to catalyze and support research and innovation that will ultimately reduce the prevalence and impact of Alzheimer’s disease and related dementias. Leveraging the diversity of Eastern North Carolina and our strong scientific environment, we will enable novel research to identify opportunities to intervene in the years before Alzheimer’s disease symptoms arise and to reduce racial and urban/rural disparities associated with dementia.